Development and optimization of a peptide inhibitor of influenza virus splicing for broad-spectrum antiviral therapy

PROJECT SUMMARY:
In this grant proposal, we aim to develop the L7Ae protein as a therapeutic for treating Orthomyxoviridae family
infections. Our approach includes three aims: (1) Investigating the mechanism of action of L7Ae on various
family members, focusing on its interaction with the conserved k-turn recognition domain in the L30 RNA-
binding proteins, to identify key viral targets and understand how L7Ae disrupts the viral life cycle. (2)
Characterizing a recently developed L7Ae transgenic mouse model that shows normal development but
resistance to influenza A virus, providing an independent platform to study L7Ae's effects on host and virus
biology. (3) Assessing the administration of recombinant L7Ae in vivo by introducing it into mouse lungs and
evaluating lung function parameters and histological analyses to examine its impact on lung morphology and
inflammation, thereby evaluating potential adverse effects on the host. Our ultimate goal is to generate
preclinical data on L7Ae-mediated treatment for Orthomyxoviridae infections, aiming to advance it towards a
clinical usage.

Public health relevance
PROJECT NARRATIVE: We aim to develop a broad-spectrum antiviral for influenza virus infections by characterizing a protein that can inhibit a key biological process in the Orthomyxoviridae family, which includes influenza A and B virus strains. If successful, this research could yield a therapeutic that would be effective against all past, present, and future strains of any member of this expansive viral family.